Graduate Training in Demography

SUMMARY
We are requesting continuation of the NICHD training grant in Demography to the University of Pennsylvania
(Penn). The proposed program continues Penn's longstanding excellence in training in Demography and will
be enhanced by (a) the creation of a new training workshop, (b) the formalization of a research apprenticeship
program, (c) improved cross-fertilization with Penn's graduate program in Sociology, (d) the recruitment of
new training faculty from multiple disciplines, and (e) expanded activities to enhance diversity. Six pre-
doctoral positions (no post-doctoral positions) are requested. The principal aim of the Demography pre-
doctoral program at Penn is to train independent researchers who are prepared to play leading roles in
population analysis. This goal is achieved through (i) intensive instruction in the methods, theoretical
approaches, and empirical substance of demography and allied disciplines; (ii) progressive incorporation of
students into faculty research activities; and (iii) subsequent branching into independent research. The
training in Demography described in this proposal reflects a vision of the population sciences and population
health in which a strong background in the logic of demographic process is the gateway to the application of
contributions from elsewhere in the social and behavioral sciences to an array of topics of public and scientific
interest.

Public health relevance
NARRATIVE The principle aims of the Training Program in Demography at the University of Pennsylvania accord with the NICHD Population Dynamics Branch's (PDB) mission to “support research and research training in demography, reproductive health, and population health.” In particular, training in demography as proposed in this application is essential for research on morbidity and mortality, HIV/AIDS, fertility, families, population movement, and population composition that is central to the PDB mission. The Training Program in Demography builds on a strong faculty, dedicated students, a long-standing tradition, and an impressive group of alumni to maintain its ongoing relevance to the mission of NICHD, which is “to ensure that every person is born healthy and wanted, that women suffer no harmful effects from reproductive processes, and that all children have the chance to achieve their full potential for healthy and productive lives.”